Prostate Specific Anti-androgen Therapy for Localized Prostate Cancer

Abstract
Prostate cancer is the most common malignancy in men worldwide and its incidence is steadily rising. Treatment
options for early-stage prostate cancer include radical prostatectomy, prostate irradiation, or active surveillance.
Systemic anti-androgen hormonal therapy is offered to high-risk patients in combination with radiation therapy
and in men with advanced or metastatic prostate cancer. Promising data from the ENACT trial has suggested
that hormonal therapy with a second-generation anti-androgen, enzalutamide, may benefit men on active
surveillance. Daily oral enzalutamide for one year reduced the rate of prostate cancer progression but came at
the cost of considerable systemic side effects. Thus, there is an unmet need as well as an opportunity to define
novel therapeutic strategies for early-stage prostate cancer. We propose to address this unmet need by
developing polymer-based drug loaded seed implants. These seed will be surgically placed into the prostate with
the goal to provide sustained anti-androgen therapy while minimizing systemic side effects.
In extensive preclinical testing and clinical proof of principle studies, we have shown that we can deliver short-
term therapeutic doses of bicalutamide pre-prostatectomy and in combination with radiation therapy. Leveraging
our prior experience, we therefore propose to develop a long-term drug delivering seed implant containing a
second-generation anti-androgen for men with early-stage prostate cancer on active surveillance. The optimal
seed implant would deliver therapeutic drug levels selectively to the prostate gland for at least two years and will
be inserted via a minimally invasive surgery performed in a community practice setting.
In two aims we propose in Aim 1 to develop an optimized lead implant formulation of each of the three approved
2nd-generation antiandrogens (enzalutamide, apalutamide and darolutamide) and in Aim 2 to evaluate these
seed implants in a short-term feasibility in vivo rat study (Aim 2a) and a long-term in vivo rat study to determine
the pharmacokinetic and pharmacodynamic profile of seed implant formulations (Aim 2b) when deployed into
the rat prostate. The first, short-term, 2-week study will include three cohorts of optimized lead seed implant
formulations containing enzalutamide, apalutamide and darolutamide and one control cohort with a bicalutamide
implant to evaluate safety, feasibility, and short-term PK profiles in prostate, plasma, and other tissues. The long-
term study with the same four cohorts will evaluate drug distribution across the prostate, anti-androgen tissue
effects, and residual drug content in recovered seed implants to estimate cumulative drug elution at 2, 4 and 6
months. All implants will be designed for easy surgical insertion. This data will allow the selection of the most
promising seed implants to advance to further IND-enabling studies for Ph1 clinical trials in men with early-stage
prostate cancer and initiate collaborations with industry partners for clinical development and commercialization.

Public health relevance
Public Health Relevance Prostate cancer remains the most common malignancy in men, and hormonal therapy has clearly shown to benefit many of these men, however, systemic side effects often countervail the benefits. We have devised a novel means to selectively deliver anticancer therapy to the prostate only, for men with early stage prostate cancer. In preclinical studies we will now evaluate and prepare the most promising anti-androgen eluting seed implants for clinical readiness.